Core C: Epigenetics and Quantitative Proteomics

The Epigenomics and Quantitative Proteomics Core will provide high-end omics analyses for the Program
Project to help identify and quantify protein expression and post-translational modifications (PTMs) on histone
using mass spectrometry, and to provide informatics analyses from various genome-wide experiments. Expertise
in the Core on the genomics side include analyzing data generated from next-generation sequencing and single-
cell sequencing technologies, mapping the epigenome of various cell types and cell states including aging cells
or cells in senescence, inquiring into the relationship of histone PTMs and transcription factor binding, and
functionally integrating the genome, epigenome and transcriptome. On the proteomics side, the Core is well
experienced to provide analysis of single and combinatorial histone PTMs, track cellular signaling events
(phosphoproteomics), perform targeted metabolomics on central carbon metabolism related molecules and for
identification of protein-protein interactions. This will include performing label-free and stable isotope labeled
proteomics and metabolomics experiments on high-resolution Orbitrap mass spectrometers, paired with custom
data analysis and bioinformatics. Results from all experiments will be disseminated to all Program Project team
members to facilitate further interactions and elicit helpful suggestions for future experiments. The Core is led by
Dr. Benjamin Garcia and Dr. Yemin Lan who together bring years of complimentary expertise, innovation and
experience to the P01 project.